Identifying heterogenous neuronal responses to HSV-1 infection with drop-based microfluidics

Project Summary
The outcome of Herpes Simplex Virus type 1 (HSV-1) disease depends heavily on whether neuronal
replication phenotypes trend towards a productive or silent infection. However, the variables which govern
these heterologous infection phenotypes are not fully understood. Identification of factors which influence the
outcome of neuronal replication is essential to develop new treatments for severe disease and alleviate the
global burden of HSV-1.
A major limitation to the study of heterologous infection phenotypes is that they are quickly lost in traditional
culture models, typically being overwhelmed by secondary viral spread from productively infected cells. Our
solution to this problem is to incorporate drop-based microfluidic technology that allows detection of diverse
viral replication outcomes with single-cell resolution. We have developed a method to grow and infect primary
neurons using a micron-scale, hydrogel bead (microgel), that permits single-cell experimentation within an
isolated environment. Our proposal aims to investigate the conditions and factors that give rise to heterologous
outcomes of neuronal HSV-1 infection with the ultimate goal of better understanding the determinants of HSV-1
disease.
This proposal will combine the development and characterization of in-drop neuronal infection to address
critical questions about HSV-1 infection and disease. The first aim will focus on classifying the outcomes of
viral replication in different neuron types. The second will use single-cell transcriptional profiling of infected
neurons to identify transcripts that promote productive or silent HSV-1 infection. Specific Aim 1 focuses on
quantifying heterologous phenotypes of HSV-1 infection in neurons. We will utilize drop-based microfluidic
separation and analysis of HSV-1 infected neurons. Outcomes of viral infection will be measured by HSV-1-
expressed fluorescent proteins and in-drop PCR detection of viral genomes. We expect that the extent of viral
replication reflects the capacity for different cellular environments to support HSV-1 infection. Specific Aim
2 focuses on single cell transcriptional profiling of productive or silent HSV-1 replication in neurons. We will
implement in-drop single-cell RNA-sequencing to profile viral and cellular transcripts from infected neurons.
Clustering analysis and classification of single cell transcriptomes will be based on the detection of viral RNAs.
The presence of individual transcripts will reflect the extent of viral replication occurring in each cell. Following
classification, correlation analysis will identify cellular transcripts that are increased or decreased with each
infection state. Together, these experiments will identify and quantify the range of outcomes for HSV-1 infection
of neurons. Subsequently, we will discover cellular genes that promote or inhibit productive viral replication by
identifying determinants of certain heterologous phenotypes. Exploring neuronal infections at the single-cell
level will provide unprecedented insight into HSV-1 replication and disease.

Public health relevance
Project Narrative The ability for Herpes Simplex virus type 1 (HSV-1) to productively replicate or establish silent infection in neurons is a poorly understood process that directly influences HSV-1 disease. In this proposal, we characterize HSV-1 replication and cellular transcription using drop-based microfluidic approaches to assess the diversity of replication outcomes with single-cell resolution. These analyses will provide incredible insight into the effect of the cellular environment on the range of HSV-1 replication in neurons and subsequent disease.